NFkB dynamics in the stimulus specificity of trained immunity

PROJECT SUMMARY / ABSTRACT
Cells of the innate immune system such as monocytes and macrophages can be reprogrammed by their
environmental context. Stimuli in the environment, such as cytokines and pathogen-associated molecules, can
dramatically alter cellular phenotype. This phenomenon, termed “trained immunity,” is driven by epigenetic
changes to the enhancer repertoire. Upon stimulation, transcription factors such as NFκB can bind to closed
chromatin regions, open the chromatin, and facilitate histone modification, activating previously silent regulatory
DNA elements called latent enhancers. These epigenetically reprogrammed innate immune cells respond
differently to subsequent stimulation and alter host responses to infectious diseases.
Interestingly, the effects of trained immunity are variable. In some cases, trained immunity primes the host to
produce an increased inflammatory response upon secondary stimulation, but in other cases it diminishes the
inflammatory response. Whether reprogrammed monocytes produce increased or diminished inflammatory
responses depends on what stimulus forms the memory. That is, the effects of trained immunity are stimulus-
specific. However, the mechanisms that account for this stimulus-specificity are unclear, and understanding
these mechanisms will be critical for harnessing the therapeutic potential of trained immunity.
The central hypothesis of this grant is that different dynamic features of NFκB activity contribute to the stimulus-
specificity of trained immunity. NFκB is a ubiquitous transcription factor that is considered the master regulator
of inflammatory gene expression. Although nearly all pathogens and cytokines activate NFκB, they do so with
varying dynamics. In particular, some stimuli induce an oscillatory pattern of activity, while others induce a non-
oscillatory pattern of activity. We have shown that non-oscillatory NFκB results in more de novo enhancers than
oscillatory NFκB using a mouse model in which NFκB oscillations are perturbed. Aim 1 of this proposal
characterizes the stimulus-specificity of training in vivo and tests the hypothesis that trained immunity produced
by different NFκB dynamics differentially alters host response to secondary infection with Candida albicans. Aim
2 investigates the mechanisms by which NFκB dynamics-dependent enhancers regulate gene expression.
This mentored career development award will support the training of a promising junior faculty member at UCLA.
The specific training objectives are to acquire expertise in 1) bioinformatics, 2) mouse models of infection, 3)
immune profiling of tissue samples, and 4) the field of innate immune memory. Training will occur through
mentorship by senior faculty members, coursework, seminars, and international conferences. The goal of this
career development award is to establish the principal investigator as an independent physician-scientist,
ultimately producing diagnostic and therapeutic tools for immune-mediated complications of infectious diseases.

Public health relevance
PROJECT NARRATIVE Cells of the innate immune system can be reprogrammed by exposure to stimuli such as cytokines or pathogens in a phenomenon known as “trained immunity.” This can make immune cells either more inflammatory or less inflammatory in response to subsequent infections, but what determines whether a given stimulus will result in potentiated or diminished inflammation is unclear. This proposal explores the hypothesis that dynamic features of the transcription factor NFκB – not if it is activated, but how it is activated – contribute to the stimulus-specificity of trained immunity through the regulation of latent enhancers that control gene expression.